ED2PrEP - patient focused, low-burden strategies for PrEP uptake among emergency departments patients: a cross-over hybrid implementation-effectiveness trial

ABSTRACT
There is substantial variability in HIV pre-exposure prophylaxis (PrEP) access and use among communities
most impacted by the HIV epidemic. The Bronx, NY is an Ending the HIV Epidemic (EHE) priority county with
the fifth highest HIV diagnosis rate in the U.S. and the lowest PrEP use in NY. Research on barriers to PrEP
engagement indicate that the current structure of PrEP access and management is not consonant with the
lives, priorities, or needs of those hardest hit by the HIV epidemic. Many of the same barriers leading to poor
PrEP uptake in hard hit communities also drive members of these communities to seek care for sexually
transmitted infections (STIs), a known risk factor for HIV, in Emergency Departments (EDs). However, there is
a discordance between the type of care likely to preserve the long-term health of those seeking STI care in
EDs (longitudinal, behavioral, and prevention-oriented) and the care the ED is optimized to provide (acute, high
intensity, life-saving/stabilizing), meaning that both patients and health systems stand to gain from a
restructuring of how STI care is delivered in EDs. Innovative, efficient, and sustainable strategies for identifying
and engaging those eligible for HIV prevention who are seeking sexual healthcare in EDs are thus needed. We
therefore propose ED2PrEP, a pragmatic Type III hybrid effectiveness-implementation trial comparing two
strategies for increasing PrEP uptake among patients at risk for HIV accessing care in Bronx EDs. The two
strategies are (1) Post-Visit Outreach (PVO) involving proactive outreach to patients following a STI-related ED
visit. PVO will be initiated by a Sexual Health Navigator who will provide PrEP education, counseling, and
linkage to existing sexual health/PrEP clinics. (2) Tele-PrEP (TP) will involve a real-time telehealth visit with a
Sexual Health Provider during STI-related ED visits. TP will also include education, counseling, and linkage, in
addition to the provider’s ability to prescribe PrEP at the time of the visit. To test the effectiveness of PVO and
TP for increasing PrEP uptake among patients accessing STI care in the ED, we will perform a crossover trial
in which the strategies are implemented in two different EDs for 9 months and then switched for another 9
months (Aim 1). Next, guided by the RE-AIM framework, we will assess implementation outcomes for the
strategies to identify how each strategy’s effectiveness is impacted by implementation considerations (Aim 2).
Finally, to inform scale-out locally and nationally, we will perform an economic analysis to determine each
strategy’s cost per outcome and relative cost-effectiveness (Aim 3). ED2PrEP will generate critical data that
could transform how EDs initiate PrEP and engage patients at the highest risk for HIV and accelerate EHE
goals in one hardest hit jurisdictions in the U.S. Findings could also be informative to other jurisdictions, having
dramatic effects on how HIV prevention is delivered.

Public health relevance
Severe inequities in HIV pre-exposure prophylaxis (PrEP) access and use in communities hardest hit by the HIV epidemic persist, further exacerbating ongoing racial/ethnic and socioeconomic disparities in HIV incidence. In these same communities, many patients at risk for HIV seek care for sexually transmitted infections (STIs) in Emergency Departments (EDs), but the structure of traditional ED care is poorly suited to address HIV prevention or provide PrEP. To advance the Prevent objective of the Ending the HIV Epidemic (EHE) initiative, ED2PrEP will leverage an implementation science approach to rigorously test two innovative strategies for increasing PrEP uptake among patients seeking STI care in EDs in one of the 48 EHE-identified geographic hotspots.